Training grant in hemostasis and thrombosis

PROJECT SUMMARY/ABSTRACT
The University of Pennsylvania (UPENN) and Children's Hospital of Philadelphia (CHOP) have directed an
NHLBI-sponsored T32 training grant supporting pre- and postdoctoral trainees in the interrelated areas of
hemostasis and thrombosis for the past 20 years. The goal of the program is to prepare these trainees for
careers in the blood sciences as successful investigators working in the areas related to hemostasis and
thrombosis that include academia, research institutes, and industry (pharma/biotech). UPENN and CHOP have
one of the largest concentration of investigators in the country interested in basic, translational, and clinical
research focused on uncovering new mechanistic insights and therapeutic interventions related to hemostasis
and thrombosis. We draw upon 31 of these talented faculty members, eight of which are young trainers and 10
of which are female, to mentor and train our students/fellows and provide them with an integrated, collaborative
experience to ensure a rich pipeline of scientists interested in hemostasis and thrombosis. In addition to
rigorous scientific training (specific aim 1), our program has an intensive hemostasis and thrombosis didactic
curriculum (seven unique components; specific aim 2) and fosters development of key core competencies
such as responsible conduct of research, communication/writing skills, professionalism, management skills,
and career development tools all supported by the rich infrastructure at UPENN and CHOP (specific aim 3).
Dr. Rodney Camire is the Program Director and Dr. Douglas Cines is the Co-Director and they oversee all
aspects of the training program. Further, the program receives critical feedback from five Internal and three
External Advisory Committee members, along with successful former T32 alumni, who assist the Program
Director to monitor the progress of the trainees (specific aim 4). Since the last funding cycle, we modified the
total number of trainees to 2 predocs and 4 postdocs to better capture the best and brightest available
students/fellows working with our trainers who are drawn from six Departments/Division at UPENN and CHOP
and five different graduate groups at UPENN. Since its inception in 2000, the program trained 32 predoctoral
(40% female) and 36 postdoctoral scientists (48% female) 12% of which are underrepresented minorities. Over
75% of our trainees remain in careers which are primarily research, with ~51% of our pre- and postdoctoral
trainees in academia-primarily research, ~27% in the pharmaceutical/biotech sector-primarily research, with
the remaining (21%) in research-related careers as scientific writers/consultants. We believe this program, with
an extraordinarily rich and interactive group of faculty members, provides exciting research opportunities
combined with strong didactic and mentoring programs focused on todays and emerging new challenges in
hemostasis and thrombosis. We hope to have the opportunity to train individuals who will make important
contributions to these areas of research and will become leaders in the field of hemostasis and thrombosis.

Public health relevance
PROJECT NARRATIVE For over 20 years this T32 training grant has supported pre- and post-doctoral trainees interested in hemostasis and thrombosis, areas with great clinical importance as heart attacks and strokes remain the number one cause of mortality in the western world. We are requesting renewal to maintain our rich history of mentoring in this space which is supported by an extra-ordinarily strong environment with an interactive and dedicated group of innovative and experienced faculty members. The renewed T32 will provide excellent research opportunities, while providing trainees with outstanding scientific development, mentoring, career development, and training in career growth to ensure that there is a next generation of scientists interested in the blood sciences.